Targeting glutamine metabolism to enhance the efficacy of radiopharmaceutical therapy

Inhibition of glutamine metabolism or glutaminolysis is an exciting therapeutic strategy for glutamine-dependent
cancers. Such a strategy may potentially avoid the complex upstream signaling pathways and directly prevent
cancer cells’ energy production and required building blocks, starving them to death. Altered glutaminolysis is
widespread across the disease spectrum of prostate cancer (PC) and renal cell carcinoma (RCC). The first step
of glutaminolysis is mediated by glutaminase, which produces glutamate (Glu), an essential precursor for the
biosynthesis of amino acids, nucleic acids, and energy production. In radiotherapy, where DNA damage is the
central mechanism of cell death, cancer cells undergo metabolic reprogramming to enhance Glu utilization.
Inhibition of glutaminolysis (Glni) has been increasingly used with radiotherapy to overcome radioresistance.
However, the effect of targeted radiopharmaceutical therapy (RPT) on glutaminolysis remains unknown. To fill
this gap, we will systematically evaluate the effect of prostate-specific membrane antigen (PSMA)-based
radiopharmaceutical therapy (PSMA-RPT) on glutaminolysis using apporved, 177Lu-/225Ac-PSMA-RPT in
experimental models of PC and RCC to deliver a mechanism-driven combination therapy. Since metastatic
castration-resistant PC (mCRPC) is associated with high PSMA expression and PSMA is a Glu producing
enzyme, PSMA has a critical role in mCRPC metabolism by utilizing a glutamine-independent metabolic
pathway. Also, metastatic RCC is highly glutamine-dependent, and glutamine-deprived tumor neovasculature
likely overexpresses PSMA to generate additional Glu to meet their high metabolic demand. Our preliminary
data show that glutaminolysis is differently regulated in PSMA+ RCC tumors to address 225Ac-L1-induced DNA
damage for their proliferation and growth. Additionally, our data revealed that Glni may upregulate PSMA levels
in PSMA+ tumor models. Based on our preliminary data, we hypothesize that PSMA-RPT will significantly affect
the glutaminolysis of PC and RCC, and Glni will expand the therapeutic window of PSMA-RPT. We have two
Aims. In Aim 1, we evaluate the effect of PSMA-RPT on glutaminolysis as monotherapy and in combination with
pharmacological (Aim 1a) and with genetic inhibition in PC and RCC cell lines (Aim 1b) to determine its role in
DNA damage. In Aim 2, we will evaluate the effect of PSMA-RPT in selected preclinical models of PSMA+ PC
and RCC in immunodeficient mice (Aim 2a) and immunocompetent mice (Aim 2b) as monotherapy and in
combination with two selected inhibitors targeting the glutaminolysis pathways from Aim 1. We have established
several human and mouse PSMA+ RCC and PC isogenic cell lines and a stable patient-derived RCC model for
the proposed research. We will take advantage of our established PSMA-based research within our cancer
center to expand the scope of PSMA-RPT for prostate and non-prostate malignancies. If successful, this project
will uncover new insights into RTP-induced metabolic changes associated with DNA damage and will deliver
mechanism-driven combination therapy beyond the existing paradigm.

Public health relevance
Inhibition of glutamine metabolism has been increasingly used with radiotherapy to overcome radioresistance. However, the effect of targeted radiopharmaceutical therapy on glutaminolysis remains unknown. To fill this gap, we will systematically evaluate the effect of prostate-specific membrane antigen (PSMA)-based radiopharmaceutical therapy (PSMA-RPT) on glutamine metabolism using our clinical radiotherapeutics in experimental models of prostate cancer and renal cell carcinoma and deliver a mechanism-driven combination therapy.